Administrative Office

ABSTRACT
Under the leadership of Richard Schulick, MD, MBA, and in conjunction with the University of Colorado Cancer
Center (UCCC) Senior Leadership, the Administrative Office (AO) develops policies and procedures to support
and promote the strategic vision for cancer research across UCCC partner institutions and external
constituencies. The AO, working alongside UCCC scientific leaders, provides oversight and infrastructure to
support the implementation of strategic initiatives that promote collaborative, multi- and transdisciplinary activities
and research across the UCCC. The AO also provides and coordinates administrative support and financial
oversight for the other operational units across the cancer center. The UCCC AO is responsible for:
 Research administration, including oversight of the grant portfolio, CCSG-related activities, intramural
funding opportunities, and design of research management databases to ensure accurate reporting
 Management of UCCC membership, including application processes, and annual reviews
 Financial management of all operational units and fiscal resources within the center, including
philanthropic, institutional and University of Colorado Hospital administrative, and clinical support funds
 Facilities management of all assigned UCCC space and equipment
 Coordination of faculty recruitment and retention in collaboration with other university schools,
departments, and divisions
 Administrative oversight and support for UCCC-supported shared resources, including the establishment
of user fees, billing, auditing, coordination of and participation in oversight committees, evaluations, and
campus-wide shared resources fairs
 Coordination of communications, including public relations, publications, website, social media, and
internal communications
 Coordination of and participation in center-wide strategic planning and evaluation efforts; including a
comprehensive, 5-year UCCC Strategic Plan developed over a 16-month time period with the assistance
of two external consulting firms and 5 quarterly meetings involving senior leadership from UCCC and its
partner institutions (CHCO, UCHealth, CU, and CSU)
 General management, operations, and decision support
 Oversight of cancer-related innovations for UCCC members, and affiliates
 Advocacy activities and Government interactions at the local, state, and federal levels including active
participation in the Colorado Cancer Caucus, Hill Day for cancer research, and coordination with
advocacy groups such as ACS, Colorado Cancer Coalition, and others
 Accountability for $189.2M investment in UCCC, over 5 years, by institutional partners